Comprehensive minimal residual disease tracking in cancer

PROJECT ABSTRACT
Liquid biopsies have made significant strides in cancer medicine, with applications spanning early cancer
detection, assessment of therapy effectiveness and drug-resistance, monitoring tumor-dynamics and early
detection of minimal residual disease, MRD. Yet, substantial questions remain, prohibiting translation to clinical
practice on many occasions. For instance, the inability to detect tumor-circulating DNA (ctDNA) in a fraction of
gliomas, gastric and renal cancers, even for advanced stages, has led to the notion that some tumors are ‘non-
shedders’, thus postulating there are biological processes preventing some cancers from shedding DNA in the
blood. If true, this would prohibit the use of ctDNA as a tumor biomarker that precedes imaging and clinical
manifestation of disease. Similar questions apply to early-stage tumors that test negative for ctDNA, but patients
do experience clinical recurrence: was ctDNA never there or was it simply too low to be detected? Yet, improved
detection techniques applied to ‘non-shedder’ cancers have recently led to major increases in the ctDNA
detection rate, converting previously ctDNA-negative samples to positive. This indicates that possibly all cancers
shed DNA in the circulation, but some can only be detected with methods providing extremely high sensitivity.
This R01 competing continuation builds on two technologies developed during the first grant cycle and
can address the questions. (a) MAESTRO -minor allele enriched sequencing through recognition
oligonucleotides- that enables extremely high sensitivity MRD detection. And (b) Duplex Repair (DR) that
reduces noise during subsequent duplex sequencing. We aim to show that the combined technology, DS-DR-
MAESTRO enables detection of ctDNA as sensitive as a single tumor-cell genome-equivalent circulating in the
~5l human blood pool at the time of blood collection, while retaining specificity. This sensitivity can be achieved
following sequencing of the primary tumor and collecting total circulating-DNA (cfDNA) typically recovered from
a standard 10-40ml blood collection. We will optimize the technology to the level required for subsequent
application in clinical studies. Aims 1-2 will optimize the technical aspects of the technology using serial dilutions
of cfDNA from tumor patients and normal volunteers. Aim 3 will apply the technology for detection of minimal
residual disease in circulating DNA from esophageal cancer patients whose tumors tend to shed very little ctDNA.
Successful technology development is anticipated to extend the use of cfDNA for detecting MRD in low-shedder
cancers and significantly shrink the size of cancers detectable. It will also increase the predictive power for
multiple endpoints, and assist pre/post-surgery ctDNA management decisions, thereby providing a window of
opportunity for many additional patients and improving precision medicine.

Public health relevance
PROJECT NARRATIVE Liquid biopsies have made significant strides in cancer medicine but substantial questions remain, such as whether cancers which shed little tumor DNA into blood could be detected with higher sensitivity methods. This proposal builds on work performed during the first cycle of this grant, aiming to develop and optimize a new technology, DS-DR-MAESTRO (minor allele enriched sequencing through recognition oligonucleotides), that affords extremely high sensitivity to detect circulating tumor DNA. The optimized DS-DR-MAESTRO technology will be applied in detecting MRD in samples collected from esophageal cancer patients, a type of cancer that is notorious for shedding low amounts of DNA in circulation.